Yale SPORE in Lung Cancer Career Enhancement Program

PROGRAM SUMMARY
The number of physician-scientists working in lung cancer has not kept pace with the overall growth of the
medical research community or with the growth in our basic knowledge base, resulting in an increasing number
of unrealized basic and translational research opportunities. Yale is uniquely suited to helping rebuild this base
with our strong commitment to translational research. The Career Enhancement Program (CEP) of the Yale
SPORE in Lung Cancer (YSILC) has been designed to contribute substantively to ongoing efforts and new
initiatives attempting to address this problem. The goal of the CEP is to educate a new generation of
investigators committed to translational research in lung cancer. The CEP has substantial institutional
commitment, both in terms of funding and infrastructure. For example, our translational research office at Yale
(also led by Dr. Herbst, YSILC PI) has been committed to providing early seed funding and translational
support to young investigators early in their research careers. Potential CEP candidates include promising
junior faculty who are interested in establishing their careers in translational lung cancer research and/or
established investigators whose previous research has been in other areas and would like to transition into
lung cancer focused research. Junior faculty awardees will be paired with mentors who are more established
lung cancer investigators with a documented record of successful mentoring. In this way, the YSILC will
stimulate the development of the next generation of physician scientists, addressing the most challenging
issues in lung cancer research.

Public health relevance
PROGRAM NARRATIVE The Yale SPORE in Lung Cancer’s Career Enhancement Program is a key program to foster the development of the next generation of physician scientists focused on conducting research in the area of human thoracic malignancies to advance discoveries in the prevention, diagnosis, and treatment of lung cancer.